Research Education Core

ABSTRACT – RESEARCH EDUCATION CORE
Disparities in health care based on race/ethnicity represent a mutable factor that costs the U.S.
government billions of dollars annually. According to the National Academy of Science Board on Higher
Education, Blacks, Latinos and Native American tribal people together represent approximately 25% of
the nation’s populations, yet they represent only 8% of the total science and engineering PhD recipients.
The Florida-California Cancer Research, Education & Engagement (CaRE2) Health Equity Center,
is a collaboration among Florida A&M University (FAMU, a Historically Black College and University
{HBCU}), University of Florida (UF) and University of Southern California (USC) that will advance cancer
research to better meet the needs of Black and Latino communities. In response to the Comprehensive
Partnerships to Advance Cancer Health Equity (CPACHE) U54 PAR, the CaRE2 Health Equity Center
Research Education Core (REC) is proposed to meet the cancer research education needs of
underrepresented minorities (URM) in Florida and California, especially Blacks and Latinos. The REC
will: (1) support the training of 30 URM post-bac students in a one-year mentored research and training
program (“Postbac-CaRE2”); and (2) provide academic career development, mentorship, and tailored
research training opportunities to increase the competitive research capacity for a total of 90 URM
graduate students, post-doctoral fellows and early-stage investigators and 40 ongoing trainees
(CaRE2-Grad+); (3) Evaluation of CaRE2 Research Education activities. Post-baccalaureate trainees at
each partner site will have a year-long immersion in research, working with multidisciplinary teams to
build their knowledge of research and to promote their academic career paths in cancer-related health
disparities. Graduate students, post-doctoral fellows and ESIs at each site will receive intensive
mentoring, academic career development and tailored research training opportunities to promote their
successful attainment of research-related and academic milestones. Program outcomes of the REC will
be monitored with Planning and Evaluation Core support to develop a robust long-term tracking and
evaluation program of the REC activities across the diverse CaRE2 training pipelines. The Administrative
Core will use data gathered via assessment activities to implement program changes as needed to
promote the success of the trainees.